Statistical and Data Coordinating Center

The goal of the Statistical and Data Coordinating Center is to provide comprehensive statistical support, data management, publication assistance, report generation and analysis activities for DMID-sponsored clinical research trials. This includes internet-based electronic data collection, site training on data collection methods, data management, data quality control and a specimen tracking system. In addition, the contractor provides consultation on statistics, study design, protocol and study materials development, appropriate control groups, sample size, power calculations, randomization, stratification, and analysis.